Core A

ABSTRACT
The Administrative Core will provide essential administrative and scientific oversight, secretarial assistance,
fiscal administration, and ensure compliance with federal and institutional guidelines for all investigators in this
program. This Core will coordinate all interdepartmental and inter-institutional arrangements to facilitate and
optimize progress of scientific interactions. The Core will ensure scientific synergy among participants including
biostatistical oversight on all data generated.
The specific aims of the Core are to:
Aim 1. Organize budgetary and personnel resources and REDCap database for all clinical and other
patient-associated data.
Aim 2. Implement interactions between investigators to ensure scientific progress.
Aim 3. Coordinate regulatory and scientific research data results for reporting.
Aim 4. Coordinate training opportunities and facilitate faculty career development.

Public health relevance
The Administrative Core will provide oversight on all activities in Projects and scientific cores that will collectively study interactions between immune and epithelial cells to study disease heterogeneity in severe asthma.